Biostatistics and Bioinformatics Core

PROJECT SUMMARY – Core 1
This Biostatistics and Bioinformatics Core (Core 1) will serve as an essential central resource to support the
quantitative needs of research projects proposed by investigators involved in this Program Project Grant
(PPG). Specifically, this Core will provide biostatistics and bioinformatics leadership and expertise in
collaboration with the Clinical Trials and Imaging Core (Core 2) and Correlative Sciences and Immune
Monitoring Core (Core 3) to all three proposed Projects. These projects investigate the safety, efficacy and
mechanisms of novel immunotherapeutic approaches to the treatment of patients with glioblastoma, a
diagnosis with extremely poor prognosis. Project 1 investigates the use of Cytomegalovirus (CMV) pp65
loaded dendritic cell (DC) vaccines with Td pre-conditioning and CD27 monoclonal antibody in patients newly
diagnosed with glioblastoma (GBM), Project 2 assesses infusions of monocytes transfected with GBM Ag CMV
pp65-LAMP in patients newly diagnosed with GBM, and Project 3 studies oncolytic poliovirus (PVSRIPO)
immunotherapy with subsequent lomustine in patients with recurrent WHO grade 4 glioma. Innovative, state-
of-the art methodology will be used by this Core in the statistical design and analysis of proposed clinical trials
and correlative studies.

Public health relevance
PROJECT NARRATIVE – Core 1 The prognosis of patients with glioblastoma is extremely poor. This Core will provide the essential biostatistical and bioinformatics support for three research projects that investigate the safety, efficacy and mechanisms of novel immunotherapeutic approaches to the treatment of these patients. If one or more of these trials are successful, these studies have the potential to significantly improve the survival of patients with glioblastoma.